Stress Hormone Signal Transduction in Arabidopsis

PROJECT SUMMARY
Abscisic acid (ABA) is a central stress hormone in Arabidopsis that down-regulates cell proliferation and
causes cell cycle arrest. Early signal transduction networks that down-regulate cell proliferation are of key
importance for controlling mitogenesis and their mis-regulation is linked to many human diseases. The long-
term goal of this research is to achieve a quantitative understanding of the network of events that mediate early
abscisic acid signaling making use of the potent Arabidopsis and guard cell systems. We will characterize
newly identified key cellular signaling mechanisms hypothesized to control the early ABA signaling module
consisting of ABA receptors, PP2C protein phosphatases and SnRK2 and Raf-like protein kinases. Aims:
Aim I. PP2C phosphatases dephosphorylate and shut off SnRK2 protein kinases and thus ABA signaling.
Whether SnRK2 kinase re-activation is accomplished by auto-phosphorylation or by other protein kinases
remained unknown. Our recent findings show that dephosphorylated SnRK2 kinases cannot re-activate
themselves. These findings reveal that re-activation of the SnRK2 kinases, which orchestrate downstream ABA
signaling, requires phosphorylation of a specific site in SnRK2 kinases. Via a genetic redundancy screen, we
have identified the long-sought SnRK2 re-activation mechanism as Raf-like-kinases (Raf-Ks). We will
determine the mechanisms by which Raf-Ks integrate within ABA receptor - PP2C - SnRK2 and osmotic stress
signaling using interdisciplinary approaches, including new dynamic SNRK2-FRET activity nano-sensors.
Aim II. Through our recent development of an innovative genome-wide artificial microRNA-screening platform,
that is designed to silence redundant homologous genes, we have identified previously uncharacterized E3
ligase F-Box proteins that are required for ABA signal transduction. Candidate F-Box targets have been
isolated through a dominant F-Box decoy approach. The functions of the identified F-Box proteins and their
targets, including GASA signaling peptides, will be determined in the dynamic ABA signaling network through a
combination of guard cell signaling, genetic, proteomic, biochemical and ubiquitination analyses.
Aim III. Through a forward genetics screen, we have identified a chromatin remodeling factor SYD, as required
for ABA responses. We will investigate the hypothesis that rapid ABA-triggered chromatin remodeling plays a
critical role in directing the massive ABA-induced SnRK2-driven transcriptional response, based on new
findings, including genomic scale rapid differential ABA-induced chromatin accessibility shifts. Mechanisms by
which Snf2 chromatin remodeling factors mediate the ABA-induced chromatin accessibility response and how
SYD functions in specificity of ABA-induced SnRK2-driven transcriptional reprogramming will be determined.
Results from these integrated approaches will provide new and mechanistic insights into a highly-developed
cellular stress-signaling network. The principles for protein kinase and PP2C phosphatase regulation and
downstream transcriptome reprogramming are relevant to understanding multiple disease states.

Public health relevance
PROJECT NARRATIVE Protein kinases and type 2C protein phosphatases (PP2Cs) play central roles in a multitude of disease states. This research will leverage a powerful and easily manipulated system to develop an in depth understanding of the regulation mechanisms of Raf-kinases and PP2C phosphatases and will reveal how these proteins function within a signaling complex in regulating cellular signal transduction. This project will make use of a highly developed model system, an innovative genomic scale functional redundancy screening platform and a newly developed real-time kinase activity nano-reporter to substantially advance the fundamental understanding of the mechanisms mediating regulation of these proteins, which are central to numerous cell-signaling pathways and are mis-regulated in human diseases.